Neuroimage-genomic fingerprints for subtyping and prediction of Alzheimer's Disease and related dementia

Project Summary/Abstract
Alzheimer’s disease (AD) is a multifactorial neurodegenerative disease with heterogeneous pathologies that
affect the cognitive function of the brain, eventually leading to dementia. The heterogeneity of AD is manifested
both in terms of diverse neurodegeneration patterns and clinical presentations, which poses challenges in
developing effective interventions. Specifically, individual genetic variations might be associated with such
disease manifestation variability. It is crucial to unravel the intrinsic heterogeneity within the AD spectrum for
achieving personalized diagnosis, and eventually developing effective targeted intervention and disease-
modifying treatment. However, several obstacles and knowledge gaps remain: currently, the genotype-
phenotype association that defines distinctive AD subtypes is poorly understood, and current AD prediction
methods preclude the development of strategies for accurate selection of at-risk clinical trial participants and
accurate disease onset time estimation. The objective of the proposed study is to establish the connection
between AD-related genomic markers and neuroimaging phenotypes to determine the heterogeneity of AD
subtypes and their joint association with the clinical onset of dementia. We hypothesize that a) distinctive
genomic factors are associated with diverse AD-related neuropathological and clinical progression patterns;
and b) the genotype-phenotype interaction is dynamic along the AD progression trajectory, which in turn
regulates the clinical progression of dementia. We plan to develop data-driven computational models using
multi-modal imaging-genomics information, to test these hypotheses with the following two Specific Aims: (1)
to characterize distinctive subtypes of AD neuropathological patterns by constructing clinically relevant
computational neuroimaging-genomic fingerprints, and (2) to achieve accurate prediction of AD progression
through subtype-aware artificial intelligence models with novel genomic-neuroimaging integration. Our multi-
disciplinary team of experts in AD mechanism and clinical manifestation, neuroimaging, genomics,
gerontology, artificial intelligence, and biostatistics will construct and validate the generalizable artificial
intelligence models by utilizing the available data from the Alzheimer's Disease Sequencing Project (ADSP)
and the ADSP Phenotype Harmonization Consortium (ADSP-PHC), which is a multi-institutional effort for
harmonizing genomic and phenotypical data to create the largest harmonized dataset available in Alzheimer's
Disease research collected from over 39 AD-related cohorts to produce a large-scale, racially diverse,
standardized set of clearly defined data. This study will be one of the first to establish a comprehensive picture
of AD pathogenesis that (i) connects genomic-level risk factors with multi-modal neuroimaging-based
neuropathological profiles, and (ii) determines their combined effects on the clinical syndrome that leads to
dementia, thereby generating crucial knowledge to inform the development of personalized interventions.

Public health relevance
Project Narrative Alzheimer’s Disease (AD) is a multifactorial neurodegenerative disease with heterogeneous pathologies that affect the cognitive function of the brain, eventually leading to dementia. Individual genetic variations might be associated with such disease manifestation variability. Thus, this project aims to unravel the intrinsic heterogeneity within the various AD subtypes for achieving personalized diagnosis and precision medicine, and eventually developing effective treatments for AD.